Path C Colorado Produce Safety Cooperative Agreement to Implement a National Produce Safety Program

Colorado Department of Agriculture
Program Summary
The goal of Colorado’s Produce Safety Program is to improve produce safety in a historically
unregulated industry and to provide consumers with safe, nutritious produce grown, harvested,
packed or held in Colorado. To achieve the goal the Program will collaborate with the FDA and
utilize both the regulatory and educational fronts to achieve compliance with the Rule.
The Program will utilize staff dedicated directly to the Produce Safety Program’s administration
as well as administrative and inspection staff shared within the Inspection and Consumer
Services Division. This seasonal use of permanent staff will allow the Program to retain more
field staff trained to conduct inspections which primarily occur over a three month period. To
address the educational needs the Program will work with Colorado State University (CSU) to
conduct PSA Grower Training and do On-Farm Readiness Reviews under a sub award with the
CO Department of Agriculture. The Program will also develop relationships with trade groups,
and key industry stakeholders to increase awareness to the Produce Safety Rule.
Colorado passed legislation and adopted rules consistent with the Federal Rule including the
authority to conduct inspections, so long as sufficient funding to support the program was
provided by the FDA. The legislation also provided the program with the authority to establish a
mandatory registration program and administer civil penalties.
We believe that achieving a high rate of compliance can be achieved through development of
strong industry partnerships, education and regulatory enforcement. Utilizing FDA resources in
a collaborative manner along with expertise within the state to address the unique produce
landscape of Colorado’s industry will result in a Program that is consistent with the objectives of
the Produce Safety Rule and a consistent National Produce Safety Program.
To achieve this goal Colorado is requesting Path C Regulatory funding of $253,500 Band 9
based on our Farm Inventory and $270,000 for Farm Inventory and Education Band 6 based on
2017 NASS data for a total of $523,500 for the first year of the cooperative agreement.

Public health relevance
Colorado Department of Agriculture The FDA’s Cooperative Agreement Program for States and Territories to Implement a National Produce Safety Program Funding Opportunity Number - PAR-21-174 Project Period 2021-2026 Program Narrative Colorado’s Produce Safety Program, which operates as part of the Inspection and Consumer Services Division of the Colorado Department of Agriculture, aims to improve the produce safety culture by enhancing the existing produce safety program in the state. Colorado’s Path C Produce Safety Cooperative Agreement to Implement a National Produce Safety Program Plan, intends to achieve that goal with farms that grow, harvest, pack or hold produce in Colorado by expanding on what the program achieved in the previous five year period, addressing new considerations and concerns that have risen since the program began, and establish metrics to meet the seven objectives defined in this cooperative agreement. With the ultimate goal of reducing illnesses and potentially deaths related to foodborne illnesses the Program feels it is essential to meet the seven objectives and increase compliance with the Produce Safety Rule.